Mechanisms in Membrane Dynamics

Abstract: A defining feature of cells are membrane bilayers that separate them from their environment and, in
eukaryotic cells, delineate intracellular organelles with specialized functions. For cells to live and replicate, they
must be able to maintain and expand these membranes. In eukaryotes, the lipid building blocks of membranes
are made mostly in the endoplasmic reticulum (ER) and then transported to other organelles from there. While
the role of vesicle trafficking for lipid transfer between organelles has long been known, we have only in the last
decade begun to appreciate the importance of non-vesicular protein-mediated lipid transfer at so-called
membrane contact sites, where two organelles are closely apposed. Indeed, the ER, the main site of lipid
synthesis, contacts every other cellular organelle at such sites. The main focus of the laboratory is to identify
and characterize the protein residents of contact sites in order to better elucidate the still largely unknown lipid
transfer processes that occur there, their molecular basis, and their role in physiology. Contact site residents
include lipid “shuttles”, proteins that equilibrate lipids between organelles, typically one lipid at a time, in order to
fine-tune the lipid compositions of apposed contact site membranes. In addition, just in this last grant period, the
PIs group was central to the discovery of elongated lipid transfer proteins in the VPS13 family that span between
organelles and serve as bridges, with long hydrophobic grooves that solubilize lipid fatty acid moieties, allowing
for bulk lipid flow across the aqueous space between membranes. Paradigm-shifting studies from the PI’s group
and collaborator suggest that these lipid transfer bridges work in partnership with integral membrane proteins,
such as scramblases, to function in membrane expansion and organelle biogenesis, for example in the de novo
formation of the autophagosome or the yeast prospore membrane. The role of protein-mediated lipid transfer in
organelle biogenesis was unanticipated and previously thought to involve exclusively the fusion of hundreds of
vesicles, as vesicles were until recently the only known mechanism for bulk lipid movement. The PI will continue
the systematic characterization of contact site proteins and their physiological roles; emphasis going forward will
be to dissect the mechanisms by which bridge-like lipid transporters collaborate with integral membrane proteins,
including scramblases, to transfer lipids directionally from their site of synthesis to other organelles for membrane
maintenance or de novo organelle formation.

Public health relevance
Project Narrative A defining feature of cells are membrane bilayers that separate them from their environment and, in human and other eukaryotic cells, delineate intracellular compartments with specialized functions. Here we address the fundamental question how cells make and maintain these membranes. Dysfunction in membrane lipid homeostasis is linked to a number of neurological disorders, including Alzheimer’s and Parkinson’s diseases, among many others. Our work will inform regarding disease mechanism, prerequisite for the development of therapeutic strategies.